DEFICIENCY ON PULSATILE RELEASE OF GONDADOTROPINS IN NORMAL WOMEN

This study will explore the effects of administration of GnRH upon the pituitary gland and ovaries on women with abnormal menstrual function.